BSL3 Practices Core

The Biosafety Level 3 (BSL-3) Practices Core (Core 2) will support the research goals of the
Regional Biocontainment Laboratory (RBL) at the Tulane National Primate Research Center
(TNPRC) by continuing to ensure a safe and secure environment for work with high-consequence
pathogens. To do so requires monitoring and training on standard operating procedures and best
practices related to the extensive regulatory measures required for working with select agents,
including knowledge of proper biosafety, biosecurity, and incident response as well as suitability
and inventory management processes. The proposed BSL-3 Practices Core will oversee
proficiency development of staff working in the BSL-3 space and associated building systems and
provide exceptional training opportunities to ensure that all individuals using select agents are
highly qualified and experienced to do so. The Core will also develop and share learning
experiences through the TNPRC virtual platform on select agent, biocontainment facilities
management, and quality assurance best practices across the NIAID Biodefense Facilities
Network and to other NIH-funded scientists. Through these activities, the BSL-3 Practices Core
will supply training and facilitate understanding of the health, safety, and biosecurity measures
required for working with high consequence pathogens for biodefense, pandemic
readiness/response, and emerging infectious diseases.